Determine the functions of the heterogeneity of embryonic origins in shoulder girdle formation

Project Summary
Vertebrate skeletons are ontogenetically heterogeneous with multiple embryonic progenitor cell populations.
However, how bone-forming osteoblasts differentiate from distinct embryonic origins and differ in their functional
contributions to skeletogenesis remain unknown. We will answer these fundamental but relatively unexplored
questions, using the zebrafish pectoral (shoulder) girdle as a powerful model to dissect embryonic heterogeneity
in ossification. We have established the zebrafish pectoral girdle as a strikingly simple and transparent
experimental model that enables us to dissect the regulation and functions of the embryonic heterogeneity in
skeletogenesis, deploying state-of-the-art genomics, genetics, and imaging techniques. To date, we have
discovered that 1) at least four distinct cell populations (neural crest cells, lateral plate mesoderm,
cardiopharyngeal mesoderm, paraxial mesoderm) differentiate into cleithrum osteoblasts, as determined by
single cell RNA-sequencing (scRNA-seq) and genetic cell labeling; 2) the gene expression profiles and chromatin
accessibility of osteoblasts derived from diverse embryonic populations differ from each other; and 3) Gli, an
indispensable transcription factor for cleithrum formation, is a leading candidate for inducing chromatin
accessibility and osteoblast differentiation, as determined by single-nuclear assay for transposase-accessible
chromatin followed by high-throughput sequencing (snATAC-seq). Based on these compelling findings, we
hypothesize that Gli amplifies progenitor cell chromatin accessibility associated with ossification genes thus
generates functionally different osteoblasts in cleithrum morphogenesis. These functionally different osteoblasts
likely contribute to various bone morphology in the cleithrum. We will dissect the regulation and functions of
heterogeneous cell populations from distinct embryonic origins in pectoral girdle development, growth, and
homeostasis through two aims. Aim 1 will determine the distributions and functions of embryonic heterogeneity
in pectoral girdle morphogenesis, growth, and homeostasis by genetic labeling and ossification ability tests in
vitro and in vivo. We will also optogenetically ablate each cell population specifically in the cleithrum and
characterize the phenotype. Aim2 will dissect the molecular mechanisms to generate functionally diverse
osteoblasts, reflecting progenitor cell chromatin accessibility. We will identify Gli binding sites and analyze their
accessibility changes in an arsenal of Hh-Gli knockout series of fish. Then, we will investigate which cell
populations are most susceptible to the changes in the Hh-Gli signaling, investigating the difference of chromatin
accessibility and responses associated with ossification genes among osteoblasts derived from diverse
embryonic origins. Successful completion of the proposed research will provide fundamental insights into the
functions of embryonic heterogeneity in skeletal development at the single-cell level, broadly informing how
dysregulation of heterogeneous embryonic origins leads to malformation of human skeletons.

Public health relevance
Project Narrative In human congenital skeletal diseases, subparts of shoulder girdle bones malform, but the underlying etiology remains uncharacterized. While it is known that the shoulder girdle develops from multiple embryonic cell populations, the functions of heterogeneity of embryonic origins in shoulder girdle development remain unknown. This proposal will identify the regulations and functions of embryonic heterogeneity in the zebrafish pectoral (shoulder) girdle as a prominent model with its transparent and simple structure.